hiPSC-based DRG Tissue Mimics on Multi-well Microelectrode Arrays as a Tissue Chip Model of Acute and Chronic Nociception

This study is part of the NIH’s Helping to End Addiction Long-term (HEAL) initiative to speed scientific solutions to the national opioid public health crisis. The NIH HEAL Initiative bolsters research across NIH to (1) improve treatment for opioid misuse and addiction and (2) enhance pain management. This study will continue to build the evidence-basis for better treatment of opioid misuse and addiction in order to stem the national opioid public health crisis.

Public health relevance
Project Narrative: Effective and non-addictive alternatives to opioid-based pain management are urgently needed. This application seeks to develop an innovative 3D tissue-chip model of acute and chronic pain using human-derived sensory neurons, immunoreactive support cells, and microelectrode arrays. This fundamentally novel approach will enable moderate throughput, quantitative screening of potential alternative pain treatments as well as mechanistic hypothesis testing.